My Home, My Health: Place-Based Public Health Resources for Rural Educators

PROJECT SUMMARY/ABSTRACT
The proposed project, My Home, My Health: Place-Based Public Health Resources for Rural
Educators, will address future bioscience workforce needs by engaging rural underserved youth, improving
the teaching skills of informal educators, and leveraging the expertise and research of Montana's NIH-
supported scientists. Montana State University in partnership with three tribal colleges -- Salish Kootenai
College, Blackfeet Community College, and Chief Dull Knife College -- and researchers of the Montana
IDeA Network of Biomedical Research Excellence (INBRE), will build a model for how INBRE networks can
train their researchers to create outreach kits with the communities they serve in order to reach underserved
youth. Additionally, the project will draw upon the expertise and community contacts of the NIH-funded
American Indian / Alaska Native Clinical & Translational Research Program (AI/AN CTRP). My Home, My
Health will create a series of hands-on, place-based activity kits that will focus on a broad definition of
disease ecology encompassing multidimensional picture of the interplay of abiotic conditions with multiple
pathogens and hosts interacting within a whole ecosystem. The project addresses the NIH goal to "foster a
better understanding of biomedical, behavioral, and clinical research and its implications" by engaging
communities to create regionally relevant hands-on activities that will help to attract underserved audiences
to STEM, give youth the opportunity to gain and practice STEM skills relevant to bioscience professions,
and enhance educator professional development. The project team will be searching for exemplary
practices to improve STEM learning outcomes that can be measured, replicated and disseminated. The
project includes INBRE tribal college researchers and afterschool program educators in three targeted
communities: The Northern Cheyenne, Blackfeet and Flathead Reservations. My Home, My Health will train
30 INBRE researchers (undergrads, graduate students, and faculty) in science communication and
outreach so they can help design and pilot the kits with youth. The project team will also train 50 informal
educators from around Montana in how to use the project's lessons, which will improve the educators'
content knowledge of disease ecology. In total, the project will impact 2,260 youth, 50 educators and 30
early-career and established researchers. After the SEPA grant is completed, the project model will
ultimately become part of Montana INBRE's future training and outreach with 50 INBRE researchers
participating each summer. INBRE will use and lend out the kits to educators around the state and continue
to create new kits. The project team includes two PIs that are women of color and there are six Native
Americans from five tribes acting as staff and/or advisors.

Public health relevance
PROJECT NARRATIVE My Home, My Health: Place- based Public Health Resources for Rural Educators will research how to attract underserved audiences to STEM, specifically rural and Native youth. This project will move past traditional information deficit models of the public understanding of science towards a public engagement with science that fosters a multi-directional dialogue incorporating varied perspectives and responding to societal issues and concerns. INBRE researchers, alongside the communities they work with, will help build locally-relevant place- based educational kits focusing on disease ecology that will improve public health awareness and provide a model for how INBRE networks can train their students to bring their research to underserved youth in authentic and engaging ways.